Investigating Neuro-Immune Regulation by Gut Fungi

PROJECT ABSTRACT
Millions of Americans suffer from inflammatory bowel disease (IBD), a condition marked by intestinal
inflammation and abdominal pain. While the impact of the gut microbiota in IBD has been widely studied, the
gut fungal “mycobiata” —and particularly the species of fungus Candida albicans— has emerged as a potential
critical factor in this disease. While recent studies have revealed elevated levels of Candida albicans in IBD
patients correlate with increased inflammation, the mechanisms underlying this connection remain unclear. Our
research investigates how Candida albicans colonization contributes to intestinal inflammation and abdominal
pain in a murine model of fungal dysbiosis. Preliminary data suggest that fungal colonization induces neutrophil
infiltration , driving inflammation and tissue damage. We hypothesize that this inflammatory environment
affects several disease aspects, directly via the fungal toxin candidalysin, or indirectly, through key
proinflammatory cytokines . To address these hypotheses, I will use cell culture and murine models to
examine how fungal colonization and candidalysin production drive inflammation, receptor activation, or
influence abdominal pain. By exploring the direct and indirect effects of fungal virulence factors on
neuroimmunity, this work will advance the understanding of fungal-immune-neuronal interactions in IBD and
will hopefully advance the search for new potential therapeutic targets .

Public health relevance
PROJECT NARRATIVE Millions of Americans suffer from inflammatory bowel disease (IBD), a condition marked by intestinal inflammation and abdominal pain, and emerging research indicates the gut fungal mycobiome may be a contributing factor in this disease. Our research aims to investigate if fungi in the gut promote inflammation-associated pain and determine the roles of candidalysin and cytokine signaling in neuronal activation and pain modulation in states of gut inflammation.